Data Science Guided Organic Reaction Development

Project Summary
The overarching objective of this program is two-fold; 1) to develop, implement, and refine data
science and machine learning (ML) workflows to guide and streamline reaction development and
2) to democratize the use of open access data science tools by the broader chemical community.
While the use of ML in chemical research has significantly increased over the past few years,
such procedures and tools have not seen widespread implementation. With this proposal renewal,
we aim to increase the ease of access to data science workflows that use ML to enhance reaction
development in the context of organo- and bio-catalysis research. A major pillar of this work is to
produce statistical models that are both predictive and interpretive. The impacts of predictive
models are highly practical for synthetic chemistry including the optimization of reaction metrics
for both target oriented campaigns and for general reaction development. The power of
interpretive models is they not only yield fundamental insight into origins of chemical reactivity but
they also require a chemist to be in the loop thereby providing the foundation for hypothesis driven
design and development. Success in using data science to build comprehensive models is
predicated on high quality data with diverse distribution in outputs (yield, selectivity, etc.).
Throughout the proposed research, we will focus on the generation of suitable data by 1) building
descriptor libraries prior to initiating an experimental campaign, 2) using dimensionality reduction
to construct chemical space maps, and 3) using algorithms to cluster and select molecules for
evaluation. For organocatalytic processes, we plan to develop workflows to explore a range of
reactions including enantioselective access to chiral bioisosteres of amide and sulfonamides
merged with new chiral phosphoric acid catalyst design and development. This integrated
approach will allow for interrogation of structural and electronic features responsible for catalyst
performance. We will also address the use of ML in biocatalysis by enhancing workflows to
circumvent and intervene in directed evolution campaigns that are stymied in terms of plateaued
mutant performance. This will be accomplished with algorithmic tools to increase data distribution
and through the development of molecular features to adequately represent the complex nature
and interactions between enzyme and substrate. The tools we are developing are aimed to be
highly adaptable and will be applied to modelling how drug molecules partition in biomolecular
condensates. Overall, we will work with a disparate group of collaborators to achieve these broad
goals and make the tools publicly available to enable their use by the broader community.

Public health relevance
Project Narrative This proposal seeks to continue our work using machine learning (ML) and data science for the optimization and interrogation of organocatalytic and biocatalytic reactions with an emphasis on sharing open access tools to enable widespread use by the chemical community. We plan to develop, implement, and refine general ML workflows to achieve predictive and interpretive statistical models for use in reaction development, directed evolution campaigns, and drug molecule solubility within biomolecular condensates. Progress in these objectives and distribution of open access tools is relevant to biomedical innovation at various research stages including, medicinal chemistry, process chemistry optimizations, and novel drug discovery pathways.